Administrative Core

Summary/Abstract (Administrative Core A)
The goal of this U19 application is to understand how internal states influence decision behavior
and brainwide neural activity, across multiple timescales, by bringing together experimental and
theoretical researchers who are already part of an established collaboration, the International
Brain Laboratory. To enable these diverse groups to work together smoothly and achieve our
scientific goals, the IBL has developed proven, effective methods for collaboration across multiple
institutions and time zones, which the U19 team will use to ensure successful completion of the
scientific aims.
The Administrative Core will coordinate all U19 program functions; provide rigorous fiscal
oversight of research projects and cores; guide and facilitate interactions among project and core
leaders, principal investigators, and research staff; and facilitate data sharing and collaboration
with key stakeholders and the broader neuroscience community. In addition, we will provide
administrative and fiscal support to enable projects and cores to make efficient use of U19
resources. The core will track the quality and productivity of IBL U19 team members, monitor and
ensure timely processing of all financial transactions, manage the subawards to partner
universities, and coordinate yearly progress reporting to NIH. This core will also arbitrate resource
allocation and assist with conflict resolution if required. Finally, we will convene an External
Scientific Advisory Board composed of experienced research scientists with proven leadership to
oversee the U19 program’s infrastructure, scientific direction, and development of resources for
the research community.
Moreover, the Administrative Core will provide structure and guidance to ensure strong
communication among core and project leaders and participants, thus ensuring integration of the
cores and projects, and fostering a team-based approach to achieving the aims of the program.
Using the collaboration’s existing structure, this integration will be achieved through regular
general-assembly and working-group meetings, as well as organized activities to promote cross-
disciplinary knowledge transfer and a strong sense of community among faculty, post-docs,
students, and staff participating in this project. In these ways, the Administrative Core will ensure
that the U19 project runs smoothly, efficiently, and cost-effectively to reach its research goals,
and that the resulting research and tools are made freely available to the broadest possible
community.